Monitoring the development of resistance to the novel insecticide clothianidin in Anopheles gambiae

Project Summary/Abstract
Despite ongoing efforts to diversify malaria control interventions with new
technologies such as the use of transgenic mosquitoes to suppress or replace
wild vector populations, insecticides remain the cornerstone of strategies aimed
at reducing the global burden of this disease. In sub-Saharan Africa in particular,
the massive deployment of long-lasting insecticidal nets and indoor residual
spraying has contributed to a significant reduction in malaria incidence in just two
decades. For this reason, the development of insecticide resistance currently
observed among vector populations is regarded as a very serious thread that can
quickly undermine recent gains in malaria control. To preserve the effectiveness
of insecticides used for malaria vector control, target interventions informed by
sufficient knowledge of the susceptibility profile of local populations are more
than crucial. Our project aims to study the development of resistance to
clothianidin, a new insecticide recently approved for indoor residual spraying. To
achieve our goal, we will capitalize on an international collaboration between
Liverpool School of Topical Medicine in the UK, Centre for Research in Infectious
Diseases in Cameroon as well as notional and international partners directly
involved in the fight against malaria in Cameroon. This collaboration will foster
capacity building and transfer of technologies in order to promote the use state-
of-the-art genomic and functional genomic tools to address the underpinnings of
insecticide resistance in malaria vectors in endemic countries. The specific aims
of our project are: 1) to monitor the susceptibility of An. gambiae to clothianidin in
Cameroon, 2) to evaluate the development and establishment of resistance in
clothianidin-selected populations of An. gambiae, and 3) to determine the genetic
loci underlying resistance to clothianidin.
!

Public health relevance
Project Narrative The use of neonicotinoids in agricultural pest management is contributing to reduce the susceptibility of mosquito populations to clothianidin, a neonicotinoid recently approved for use in indoor residual spraying targeting malaria vectors. Our project aims to test whether the utility of clothianidin in public health is currently being threatened in some agricultural regions in Africa. This research will be very important to preserve the efficacy of this active ingredient in malaria vector control. !